MAPPING SITES OF N-LINKED GLYCOSYLATION ON PGIP

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The goal of this collaborative project is to use N-linked site mapping strategies to identify the occupied sites on PGIP and to define the N-liked glycans present on the purified protein.